Cortical organization of action knowledge before and after brain surgery

For$entire$Admin$Supp$Application$in$a$single$document,$please$see$ ‘ResearchStrategy’$doc.$$

Public health relevance
For$entire$Admin$Supp$Application$in$a$single$document,$please$see$ ‘ResearchStrategy’$doc.$$